Neurotensin receptor 1 as a novel target for opioid use disorder and discovery of new small molecule probes

PROJECT SUMMARY
Submitted in response to RFA-DA-24-063, we propose to develop novel, brain-penetrant, small molecule biased
allosteric modulators (BAMs) of the neurotensin receptor 1 (NTSR1) to attenuate relapse to opioid seeking in
individuals with opioid use disorder (OUD). NTSR1 is a G protein coupled receptor (GPCR) that is highly
expressed in dopamine (DA)-rich brain regions and modulates brain DA signaling. NTSR1 ligands counter the
effects of multiple classes of misused drugs. As a GPCR, NTSR1 signals via heterotrimeric G proteins and β-
arrestin proteins. While NTSR1 has long been recognized as a promising target for the treatment of chemical
addictions, development of balanced NTSR1 agonists that active both pathways is precluded by on-target side
effects (i.e., hypothermia, hypotension). Our collaborative team developed a series of first-in-class β-arrestin
BAMs of the NTSR1, which attenuate psychostimulant drug effects without the side effects characteristic of
balanced NTSR1 activation. While NTSR1 is a well-established therapeutic target for stimulant use disorders,
and its mechanism of action suggests utility that spans drug class, its validity as a target for OUD has not been
rigorously established. The limited data available on NTSR1’s effect on opioid action is promising. Our data
suggest that first generation β-arrestin NTSR1 BAMs act via a reward mechanism conserved across drug classes
and attenuate both stimulant and opioid drug self-administration. In aim 1, we will validate NTSR1 as a drug
target for the treatment of OUD with our optimized lead BAMWe will leverage a mouse model of relapse to
intravenous (IV) opioid seeking, NTSR1 knockout (NTSR1-/-) mice, and our extensive knowledge of β-arrestin
BAM pharmacology. Recently, we discovered that these compounds block NTSR1 signaling via some G
proteins, but permit signaling via others. Because balanced NTSR1 agonists promote drug seeking, we
hypothesize that this G protein permissiveness detracts from the therapeutic utility of these BAMs in OUD. In
aim 2, we will discover next generation β-arrestin BAMs for NTSR1 with improved β-arrestin selectivity
to test this hypothesis. We conducted comprehensive signaling characterization for a panel of ligands from our
lead series. In addition, we have robust cell-based assays (and appropriate counter-screens) to reliably monitor
NTSR1 activation of more than 14 transducers. Leveraging these assets, we will conduct a medicinal chemistry
campaign to increase the potency and β-arrestin selectivity of BAM scaffold, with a flow scheme consisting of
cell-based receptor signaling assays and early assessment of ADME, brain penetration, and central NTSR1
engagement. We have stringent criteria for second-generation leads. Compounds that match this profile will be
advanced to efficacy testing in a model of relapse to IV remifentanil seeking in wild-type and NTSR1-/- mice. This
multidisciplinary research plan capitalizes on the unique scientific and drug discovery expertise of our team and
is a critical step towards our goal of developing therapeutics to facilitate recovery in individuals with OUD.

Public health relevance
PROJECT NARRATIVE Misuse of opioid drugs and opioid overdose pose major public health concerns. Existing medications for opioid use disorder (OUD) are inadequate, as evidenced by the high rate of relapse to opioid seeking and opioid- associated deaths. Here, we propose to validate the neuropeptide receptor neurotensin receptor 1 (NTSR1) as a therapeutic target in OUD and to discover small molecule probes for this receptor that may serve as the basis for novel medications for relapse prevention.